Characterizing and Targeting BAX- and BAK-Dependent Cell Death in Cancer

PROJECT SUMMARY
The incorporation of Immune checkpoint blockade into anticancer armamentarium has revolutionized cancer
therapy in recent years, with FDA approved agents in multiple cancer types. Nevertheless, there is an urgent
need to identify additional therapeutic strategies to increase durable response rates. Induction of immunogenic
cell death is one of such strategies. The BCL-2 family proteins are central regulators of mitochondrial apoptosis
and consist of (1) multidomain antiapoptotic BCL-2, BCL-XL, and MCL-1, (2) multidomain proapoptotic BAX
and BAK, and (3) proapoptotic BH3-only molecules (BH3s). BAX and BAK are the essential effectors of MOMP
whereas BCL-2, BCL-XL, and MCL-1 preserve mitochondrial integrity. BH3s are death sentinels that relay
upstream apoptotic signals to initiate apoptosis by either activating BAX/BAK or inactivating BCL-2/BCL-
XL/MCL-1. Through an interconnected hierarchical network of interactions, the BCL-2 family proteins integrate
developmental and environmental cues to dictate the survival versus death decision of cells. The research on
the BCL-2-regulated apoptotic pathway has not only revealed its importance in both normal physiological and
disease processes, but has also resulted in the first anti-cancer drug targeting protein-protein interactions.
Recent paradigm-shifting discoveries have shown that BAX/BAK activation in the absence of caspases can
trigger the release of mitochondrial DNA to the cytosol through a process called “mitochondrial inner
membrane permeabilization” (MIMP), which in turn activates the cGAS/STING pathway and type I interferon
response. Hence, the BCL-2 family plays a crucial role not only in the decision of cells to live or commit suicide
but also in the decision to die in an immunologically silent or inflammatory manner. The discovery of MIMP and
its role in activating immunogenic cell death opens up exciting new avenues for cancer cell death research.
However, the molecular and biochemical basis of MIMP remains uncharacterized. Furthermore, it is unclear
whether induction of MIMP in tumors will affect the tumor-immune crosstalk and immunotherapy response. In
this grant application, we have formulated a comprehensive plan to interrogate the biochemical and molecular
basis of MIMP and exploit MIMP as a therapeutic strategy to improve and enhance immunotherapy. Our
studies will not only provide novel mechanistic insights into the BCL-2-regulated cell death program but also
lay the foundation for targeting the BCL-2 family to induce immunogenic cell death and thereby enhance
cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE Studies of fundamental cell death mechanisms provide unique opportunities for molecularly designed cancer therapeutics. The BCL-2 family proteins are central regulators of cell death and validated anti-cancer targets. We propose to investigate the molecular mechanisms by which BCL-2 family proteins regulate cell death with the hope that our study will enable novel targeted therapeutic strategies that specifically trigger cell death in cancer cells.